Development of Synaptic Pathways in Retina

DESCRIPTION (provided by applicant): Activity-dependent synaptic remodeling is a fundamental feature for both normal development and degenerative diseases of CNS. A critical barrier to fully understand activity-dependent remodeling of neuronal circuitry of CNS is the lack of the knowledge of how neuronal structure is regulated by synaptic activity. Recent studies have demonstrated that proteins typically associated with the immune system are expressed by neurons and regulate activity-dependent synaptic plasticity in the normal development of CNS and pathogenesis of many CNS diseases. Therefore, studies to identify the function of immune molecules in the synaptic remodeling of retina will provide the foundation for the understanding of the molecular and synaptic mechanisms essential for the pathogenesis in degenerative retinal diseases. The long-term goal of this study is to identify the mechanism that regulates RGC dendritic remodeling under the control of synaptic activity and T-cell receptor (TCR). We recently found that a key component of TCR, CD3ζ, is expressed in RGCs. Genetic deletion of CD3ζ significantly impairs the normal development of RGC axons and dendrites. Pharmacological blockage of glutamate receptor (GluR)-mediated synaptic activity in WT mice phenocopies the defects observed in CD3ζ-/- mice but has no additional effect in CD3ζ mutants, suggesting that CD3ζ could play a critical role in GluR-mediated dendritic remodeling of RGCs. Because a primary function of CD3ζ in immune cells is to regulate cell morphology by reorganizing cytoskeleton, we propose to further investigate whether CD3ζ directly regulates RGC dendrites via cytoskeleton reorganization. Additionally, we will determine whether GluR-mediated synaptic activity is required for the CD3ζ-mediated regulation of RGC dendritic remodeling. The first aim of this study is to determine whether CD3ζ directly and selectively regulates the dendritic remodeling of RGCs by examining RGC dendrites with gain-of-function of CD3ζ in RGCs through AAV2 virus induced expression of CD3ζ in CD3ζ-/- retinas. The second aim will investigate how CD3ζ interacts with RGC synaptic activity during development by determining whether CD3ζ regulates RGC dendritic remodeling without or with GluR-mediated synaptic activity. The third aim is to determine whether CD3ζ regulates RGC dendritic remodeling through Fyn/ZAP70-mediated signaling pathway by examining whether mutation/knockdown of Fyn and ZAP70 impairs RGC dendritic remodeling as that of CD3ζ deletion, and whether Fyn and ZAP70 interact with CD3ζ-mediated activity in the regulation of RGC dendritic remodeling. The results of these studies would not only provide important insights into how immune molecules regulate development of retinal synaptic circuits but also address the fundamental question of how changes of synaptic activity lead to changes of neuronal morphology in activity-dependent synaptic plasticity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding of how neuronal networks of the central nervous system (CNS) are formed during normal development and remodeled under pathological conditions will provide biological basis for the development of treatment strategies to preserve and reestablish the structure and function of the CNS in neuronal diseases. This proposed study will address the question of how synaptic activity and immune molecules regulate the development of retinal ganglion cell (RGC) dendrites. Accomplishment of the experiments proposed in this study would not only open up new areas of research for mechanisms of activity-dependent synaptic plasticity in the CNS but also stimulate future studies of the roles of immune molecules in pathogenesis and treatment of various neuronal diseases.